The Louisiana Center for Advancing Underrepresented Scientists Careers in Health, Nutrition, Obesity, and Disparities Research (LAUNCHED)

Abstract/Summary
It is increasingly recognized that a diverse workforce is important to academic productivity. However,
members of ethnic minority groups are currently underrepresented in academia. This underrepresentation in
academia has a direct effect on health disparities research, including studies related to nutrition, obesity,
and/or diabetes. Underrepresented minority (URM) scientists tend to engage in research that addresses issues
relevant to ethnic minority groups. In order for URM scientists to make a sustained impact on issues relevant to
the National Institute for Diabetes, Digestive, and Kidney Diseases (NIDDK), they must be able to obtain
federal grant funding. The Louisiana Center for Advancing Underrepresented Scientists Careers in Health,
Nutrition, Obesity, and Disparities Research (LAUNCHED) will
recruitment,
competing
develop a comprehensive program of
mentoring, training, and career development to increase the success rate of URM scientists
for federal research funding.The LAUNCHED proposal is a collaboration among several institutions
with existing working relationships. The project will be led by investigators from Pennington Biomedical
Research Center in Baton Rouge, LA, along with Tulane University, Louisiana State University (LSU) A&M,
LSU Health Sciences Center New Orleans (LSUHSC-NO). The program will also involve two Historically Black
Colleges and Universities including Xavier University of Louisiana, and Southern University. Two cohorts of
URM scientists (cohort members) will be recruited, and will include 10-20 mentees who will each spend 2
years in the program. Pennington Biomedical is home to several obesity and diabetes related center grants,
which will work synergistically with the LAUNCHED program to provide a comprehensive training program for
the cohort members. The center grant infrastructure will allow the LAUNCHED program to provide cohort
members with mentorship, grant writing opportunities, didactic instruction in nutrition and diabetes, and a Pilot
and Feasibility program. There will also be several components that are tailored to the specific needs of URM
scientists. The LAUNCHED program will provide didactics on diabetes, obesity, and nutrition as it relates to
health disparities. Mentors will be educated on barriers facing URM scientists and will be provided with specific
skills for working effectively with URM scientists. Senior URM scientists will interact with cohort members in
order to serve as role models and share strategies for academic success. Career coaching will be delivered by
professional coaches with experience working with URM scientists. In addition, the LAUNCHED program has
expertise in mentoring and career coaching organization to work successfully with ethnic minority women.
Ultimately, the LAUNCHED program will provide a comprehensive and data-driven training program that will
prepare URM scientists to successfully compete for NIH grant funding.

Public health relevance
Narrative Underrepresented minorities are less likely to receive independent investigator awards from the National Institutes of Health. The result is a non-diversified workforce and less emphasis on diabetes-related health disparities research. The current study (called LAUNCHED) is designed to provide underrepresented minorities with a tailored training program to increase the chance of receiving diabetes, obesity, and/or nutrition funding.